The bone marrow extracellular matrix: scaffold of hematopoiesis

ABSTRACT
This proposal addresses the urgent need to understand disease mechanisms in Primary Myelofibrosis (PMF).
PMF is a disease of dismal prognosis. The only potentially curative therapy, allogeneic stem cell
transplantation, is a high-risk procedure, with a mortality rate of at least 50%. Myelofibrosis is characterized by
excessive production of extracellular matrix (ECM), the fibers in bone marrow, which leads to a progressive
failure in blood cell production. A number of gene mutations, including JAK2V617F, have been reported in
PMF. While it is thought that hematopoietic cells carrying gene mutations abnormally proliferate and secrete
factors that stimulate stromal cells to produce ECM excessively, inhibition of JAK2 was not able to improve
disease outcomes, and complementary therapies that specifically target ECM production are not currently
available. Dependence on the prevalent hypothesis, with its focus on gene mutations, is a critical barrier to
progress in the field. This project proposes, instead, to address the problem from the ECM angle. Building on
our published and preliminary studies with mouse and human samples, the central hypothesis of this proposal,
based is that abnormal activation of integrins (adhesive molecules that mediate cell attachment to ECM)
facilitates proliferation of PMF cells (Aim 1A-C). Further, I will explore two potential mechanisms behind this
abnormal integrin activation, asking, first, whether abnormally high ECM production occurs in the vascular
niche, where PMF cells develop (Aim 1D), and, secondly, whether lysyl oxidase (LOX), a protein upregulated
in PMF, activates integrins in PMF through post-translational modification (Aim 2). As PMF proliferation arises
from interaction between ECM and integrins, the question is whether proliferation is triggered by an
abnormality in ECM formation or by direct integrin activation by LOX. These studies will be performed on the
most representative mouse model of human PMF, mice transgenic for the JAK2V617F mutation. In Aim 1A-C
the effect of integrins on cell proliferation in PMF will be determined by blocking integrin function with
antibodies and by deleting integrin genes using genetically modified mouse strains. In Aim 1D, 3D confocal
imaging will be used to determine the spatial distribution of cells, ECM and vasculature in myelofibrotic bone
marrow. In Aim 2, proteomic analysis of post-translational modifications will be performed in integrins to
determine specific lysine residues oxidized by LOX. This is a Career Development Award, and the PI of this
application will have the mentorship of investigators with expertise in the field for the execution of the project.
The project builds on previous experience of the PI in malignant hematology. The training and the expertise
acquired during this award will provide a foundation for a successful independent career for the PI of this
project.

Public health relevance
This project addresses the critical need to elucidate disease mechanisms of Primary Myelofibrosis (PMF), a disease characterized by excessive production of extracellular matrix (ECM) which inhibits production of blood cells in bone marrow. Genomic sequencing of patient samples provided detailed information of gene mutations in PMF, but the mechanism of myelofibrosis remains largely unknown. Placing ECM center-stage in the study of the pathogenesis of PMF, this project promises to open a second front against PMF that may overcome therapeutic limitations of the current gene-mutation centered approach, will deepen our understanding of how ECM affects blood production in general, and will contribute to understanding of other diseases in which myelofibrosis occurs secondarily, such as leukemias and myelodysplastic syndromes.